Wisconsin Multidisciplinary K12 Urologic Research Career Development Program

This application seeks support to continue the highly successful University of Wisconsin Multidisciplinary
Urologic Career Development Program (KURe) initiated in 2013. The NIH and Institute of Medicine have
identified a critical lack of investigators with the skills and clinical knowledge required to effectively investigate
benign urologic disorders and identify improved methods of diagnosis and treatment. This program addresses
this essential need. The 1st trainee supported by the current award now holds a tenure track faculty position in
the Department of Chemistry, with a joint appointment in the Department of Urology, at the University of
Washington, Seattle. The 2nd trainee holds a tenure track faculty position in the Department of Obstetrics &
Gynecology at the University of Wisconsin, Madison (UW), the 3rd trainee is being actively recruited for tenure
track faculty positions, the 4th trainee is a tenure track Assistant Professor in the Department of Medical
Sciences, the 5th trainee will likely leave the program in the near future due to having submitted an R01
application and receiving a score that ranked in the 5th percentile, and the 6th trainee (a URM) has only been in
the program for 1 year but has already submitted an R01 application. The UW is uniquely suited to provide
exceptional training in benign urologic research. The UW is home to 1 of 4 NIH-funded George M. O'Brien
Centers for Benign Urologic Research. The research and educational activities of the Center provide
excellent opportunities for KURe Scholars to engage with a variety of investigators on campus, establish
contacts with external collaborators, and participate in center symposia and seminars. The training program
has benefited substantially from a close and enthusiastic partnership with the UW Institute for Clinical and
Translational Research (ICTR), the administrative unit for programs supported by the Clinical and
Translational Sciences Award (CTSA) held by the UW. A stated goal of the ICTR KL2 training program is to
include recipients of other institutional or independent K awards in career development activities of the ICTR
KL2 program. The resources of the ICTR are manifold and provide a solid foundation for our recruiting,
training, and educational activities. The 12 ICTR-supported K scholars and the 5 K12 KURe scholars
comprise a critical mass that benefits from well-established programs of training and mentoring. Trainees
have the option to pursue graduate degrees or certificates in Clinical Investigation. Further institutional
support is provided through structured training in mentoring, teaching, and career development programs
offered by the office of Postdoctoral Studies and other programs. The program also works with ICTR and
other programs on campus to increase the number of underrepresented minorities and disadvantaged
individuals choosing to pursue postdoctoral training. In summary, this KURe program incorporates excellent
trainers in a variety of disciplines who prepare trainees for outstanding careers as independent researchers
focused on benign urology.

Public health relevance
Benign urological disorders such as urinary tract infection, overactive bladder, interstitial cystitis, urethral stricture, urinary fistula, neurogenic bladder, genetic basis for congenital anomalies, andrology/fertility, incontinence, and benign prostatic hyperplasia affect millions of Americans annually, resulting in well over a billion dollars in health care costs. This program provides training that prepares investigators to establish independent careers of research that address these highly significant health issues.